Research and Mentoring in Psychosocial Oncology

. This K-05 award is requested to allow William H. Redd, PhD, to devote his full-time effort to mentoring ,ostdoctoral trainees and junior faculty and to conducting research in cancer prevention and control. /Ientoring will include: l) one-to-one writing and discussions sessions in which research ideas, papers and [unreadable]eseareh protocols are reviewed/revised, 2) didactic research seminars in which substantive material relevant to cancer prevention and control is presented/discussed, 3) work-in-progress sessions in which research reports written by trainees and/or by faculty are reviewed, 4) trainee-led journal club sessions in which trainee selected published research manuscripts are reviewed/discussed, and 5) research seminars in which outside experts in cancer prevention and control present their work and consult on trainee and faculty research _roposals/studies. Mentoring/training sessions and seminars will be scheduled on a weekly or bi-weekly rests. The goal is enable trainees and junior faculty to become independent researchers and mentors in cancer _revention and control. _esearch to be conducted during the tenure of the proposed award will include: 1) ongoing prospective- Longitudinal analysis of psychosocial distress among mothers of children undergoing bone marrow transplantation / stem cell transplantation (BMT/SCT) in the treatment of cancer. 2) newly initiated randomized clinical trail investigation of cognitive-behavior therapy in the treatment of anxiety-related _ adjustment problems in adult long term survivors of BMT/SCT in the treatment of cancer, and 3) emerging research on barriers to participation in cognitive-behavioral supportive intervention among cancer patients. Trainees will participate in all aspects/phases of this research. _ERFORMANCE